Intracranial EEG to test how noninvasive stimulation affects hippocampal-dependent memory

PROJECT SUMMARY/ABSTRACT
The hippocampus plays a crucial role as part of a distributed brain network supporting memory for life events.
This exploratory project seeks to develop an evidence base for the use of intracranial EEG (iEEG) to
investigate how noninvasive stimulation can be used to modulate hippocampal network neural activity and
thereby test its role in memory. Hippocampal Indirectly Targeted Stimulation (HITS) is a noninvasive
stimulation approach that uses transcranial magnetic stimulation of parieto-occipital regions of the hippocampal
network. Previous studies indicate that HITS can selectively alter hippocampal activity observed through fMRI
and enhance memory performance. The critical challenge addressed by this exploratory project is
understanding neural mechanisms for how HITS affects network activity and behavioral performance. iEEG
offers superior temporal and spatial resolution, which will provide detailed information on how HITS affects
memory-related neural activity. The research has three primary aims: (1) investigating the selectivity of HITS
effects on iEEG activity of the hippocampal network, (2) testing whether HITS impacts the endogenous theta-
rhythmic oscillatory activity of the hippocampal network, and (3) determining if HITS specifically modifies
memory-related hippocampal iEEG activity. These aims are addressed through a series of experiments
involving HITS and detailed behavioral testing in neurosurgical patients undergoing iEEG monitoring for clinical
treatment of epilepsy. This exploratory research would establish the HITS-iEEG method and provide initial
mechanistic insights, with experiments designed to provide information to motivate future research on how
HITS could be used to address the specific hippocampal network abnormalities associated with memory
impairments in different neurological and psychiatric disorders. Relevant to the goals of PA-21-219, the
hippocampal network is disrupted in disorders that are of joint interest to NIMH and NINDS, including brain
injury, epilepsy, Alzheimer’s disease, schizophrenia, major depression, and PTSD. Positive outcomes from this
exploratory study would support future research on HITS applications to these disorders, including using
detailed knowledge of HITS effects on hippocampal network neural activity to develop targeted interventions
for the specific network abnormalities responsible for memory and cognitive impairments. Detailed knowledge
of how HITS affects brain network function will also motivate scientific applications for the use of HITS as a tool
to test theories of the brain-behavior relationships supporting memory for life events.

Public health relevance
PROJECT NARRATIVE Human intracranial EEG can provide brain-activity correlates of memory with high spatial and temporal resolution. This project will use intracranial EEG to understand mechanisms by which noninvasive neuromodulation affects the network of the hippocampus and memory performance. Findings will advance understanding of brain mechanisms for memory and their control by neuromodulation, which could accelerate progress in the treatment of memory disorders.